CRCNS: Predictive Models of Human Speech Recognition in Natural Environmental Noise

The human ability to carry a conversation in natural auditory scenes with competing talkers and environmental
noise is a critical cognitive skill. Although normal human listeners effortlessly perform this task, for instance in a
crowded restaurant, it challenges the elderly and individuals with hearing loss since even moderate levels of
environmental noise can severely compromise their speech recognition abilities. Understanding the neural
mechanisms that underlie speech recognition in real sources of environmental noise is thus highly clinically relevant.
Different types of background noise vary in acoustic structure and complexity and can interfere with speech
perception in fundamentally different ways. Yet, how the acoustic structure of the background interferes with
comprehension is not well understood. This study leverages recent advances in modeling sound "textures", such as
wind , rain, street noise or speech babble, using a biologically grounded generative auditory model to study human
speech recognition (HSR)in the presence of natural environmental noises. Texture synthesis will be used to
manipulate and control the background sound complexity and its influence on HSR behavior, with a wide range of
natural acoustic backgrounds and variants with perturbed statistical sound structure. The study includes (Aim 1)
behavioral testing to assess which elements of acoustic structure in natural backgrounds interfere with phonetic,
lexical, and segmental structure in speech during HSR, (Aim 2) human EEG studies to map out how the different
stages of the auditory system, from brainstem to cortex, cope with natural environment noise during speech
comprehension. Finally, the study will (Aim 3) develop biologically inspired computational models of HSR that are
tolerant to background environmental noise and which account for human HSR behavior and electrophysiology. This
interdisciplinary approach will contribute towards a comprehensive theory of HSR in real-world natural acoustic
environments. The combined use of human behavior, electrophysiology, and computational models, which are tested
using identical acoustic paradigms, will identify neural mechanisms and behavioral strategies for HSR and allow us to
link behavior, cognition, perception, and neurobiology. Collectively, the findings could lead to diagnostic tools that can
identify auditory deficits for speech perception, which are not easily identified in clinical settings, and new biologically
inspired auditory prosthetics that can operate effectively in a wide range of real-world settings.
RELEVANCE (See instructions):
Human speech recognition is remarkably resilient to competing environmental noise, such as in a crowded
restaurant, yet this ability is severely compromised for the elderly and populations with hearing loss. This study
proposes to stud y behavioral, neural, and computational mechanisms that humans use to segregate and recognize
speech in natural acoustic environments. This knowledge is critical to identify neural mechanisms that endow normal
hearing abilities and to develop future interventions to diagnose and treat hearing loss.
P ROJ EC / P E R FO R M AN C E SI T E(S) (if ad ditional space is need ed , use